Summer Research Fellowship Program for Podiatric Medical Students

ABSTRACT
The proposal entitled “Summer Research Fellowship Program for Podiatric Medical Students” is a short-term
training grant involving pre-doctoral podiatric medical students in biomedical research. An estimated 37.3 million
Americans (11.3% of the population) have diabetes, a serious, life-long condition. Foot pathology is one of the
most common complications associated with diabetes and podiatrists are often the first-in-line clinicians seen by
patients with diabetes. As it is a relatively young discipline, podiatry has not developed institutionalized research
in most of its schools and training institutions. Subsequently, podiatric medical students are traditionally under-
represented in research careers but provide a large pool of available talent that could be recruited in biomedical
science research. This is especially true in the field of diabetes. The Summer Research Fellowship Program
exposes first-year podiatric medical student to interprofessional research across numerous disciplines and is
often their first exposure to biomedical research. The program also provides an inclusive professional community
where students can develop the skills and mentorship required for research success. The overall goal of the
training program is to increase the number of podiatric medical students entering careers in the biomedical
sciences. We seek to achieve this goal by pursuing the following aims/objectives:
1. Provide podiatric students with individual hands-on experiences in scientific research through
mentorship from an active researcher and/or joining an existing research center at RFUMS.
2. Provide a collaborative research environment that combines experts in basic science, clinical, and
translational research, in order to optimally address individual student interests.
3. Provide podiatric students with an ongoing research support network and opportunity to maintain
involvement in research over the course of their academic medical career.
4. Provide podiatric students with educational training in data collection and analysis, scientific writing, and
oral presentation of research, and responsible conduct in research.
5. Provide podiatric students with opportunities to explore career options in medical research through
interactions with mentors, other faculty, and prior trainees.
6. Foster a sense of belonging to a community of like-minded scientists among the trainees
After completion of the summer research program, podiatric medical student have opportunities to continue their
work in one of several interprofessional programs offered by the college including the dual DPM-PhD degree
program.

Public health relevance
PROJECT NARRATIVE The Summer Research Fellowship Program for Podiatric Medical Students seeks to increase the number of podiatric medical students entering careers in biomedical sciences. This is especially important in the field of diabetes, as foot pathology is one of the most common complications affecting the 29 million people in the United States living with the disease. Students who have participated in the program have produced numerous peer- reviewed publications, research abstracts, awards and grant funding in contribution to diabetes-related research.